Role of the gut barrier in inflammatory arthritis

PROJECT SUMMARY
Antibiotic use is linked to increased risk for the onset or relapse of inflammatory arthritis, including rheumatoid
arthritis and juvenile idiopathic arthritis, but the underlying basis for this and the gut-joint axis in regulation of
both inflammatory and viral arthritis are not well understood. The goal of this proposal is to define how antibiotic-
mediated gut dysbiosis and loss of certain short chain fatty acids (SCFA)-producing bacteria alters local
responses in the gut and distal inflammation in the joint. Heterogeneity of tissue resident synovial macrophages
and fibroblasts have been described in rheumatoid arthritis but little is known about the cellular context and it
has been virtually unexplored in the context of viral arthritis. I hypothesize the antibiotic-mediated gut dysbiosis
and associated loss of certain SCFA-producing bacteria alters local intestinal epithelial responses to increase
gut permeability and the priming of systemic pro-inflammatory responses. Furthermore, I hypothesize that this
is linked to altered epigenetic and transcriptional programs in resident synovial cell populations that enhance
synovial inflammation and worsen arthritis severity. Additionally, I propose that supplementation with exogenous
SCFA can regulate these changes to temper the severity of arthritis. Using a combination of functional studies
and sequencing technologies including high resolution spatial transcriptomics and ATAC-sequencing, this
proposal will address gaps in knowledge related to how SCFA-producing bacteria shape intestinal epithelial cell
responses to modulate the severity of viral arthritis (Aim 1) and how antibiotic-mediated gut dysbiosis affects
tissue resident synovial macrophages and fibroblasts to enhance inflammation in Chikungunya viral arthritis (Aim
2). The elucidation of altered pathways may stimulate novel therapeutic approaches for modulation of gut
dysbiosis and improved clinical management of viral and inflammatory arthritis.
This proposal describes a 5-year training and mentorship plan to prepare the PI, Fang Roseanne Zhao, M.D.,
Ph.D., to become an independent physician-scientist principal investigator. The aims of the mentored research
project described provide the framework for Dr. Zhao obtain additional expertise in gut immunology, synovial cell
profiling, next generation sequencing, and bioinformatic skillsets in order to effectively study the complexity of
the microbiome and gut-joint link. Washington University School of Medicine is an ideal training environment with
a longstanding commitment to the training of physician-scientists, outstanding resources, expertise to complete
the proposed research. During the 5-year period of support provided by this K08 award, Dr. Zhao will continue
her career development through relevant coursework, collaborative learning, and mentors to allow her to obtain
foundational knowledge and transition to her own independent research program as a successful physician
scientist studying modulation of arthritis by the host-microbiome interface.

Public health relevance
PROJECT NARRATIVE Antibiotic alteration of the gut microbiota can worsen the severity of inflammatory arthritis but how this occurs is not well understood. This proposal aims to extend our prior work to define how antibiotic-induced gut dysbiosis affects local responses in the gut epithelium and distal inflammation in the joint. This Mentored Clinical Scientist Research Career Development Award (K08) application proposes a research and career development plan over the next 5 years to allow the PI to study this important research question and develop the skills and training to become a successful, independent physician-scientist investigating the gut microbiome interface and the gut- joint axis.